Development of Tetrahydrocannabivarin as a Treatment for Smokers

ABSTRACT
Tobacco use is the leading cause of preventable death and disease in the United States. The majority of
smokers report the desire to quit smoking; however only 3-5% of unaided quit attempts are successful;
highlighting the need for TUD treatments. Currently, there are only three classes of FDA-approved
pharmacotherapies for smoking cessation. While these medications have shown effectiveness in increasing
abstinence during randomized clinical trials, the benefit of using such treatments decreases over the course of
a year, and long-term quit rates rarely exceed 30%. Thus, innovations in treatment approaches are needed to
reach further reductions in tobacco use. Δ9-Tetrahydrocannabivarin (Δ9-THCV) is a phytocannabinoid, which is
thought to be a CB1 receptor antagonist and partial CB2 receptor agonist. Δ9-THCV has shown initial promise
as a novel therapeutic for nicotine dependence and addictive disorders. Evidence from several animal models
indicates that THCV reduces nicotine self-administration, reduces cue- and nicotine-induced relapse-like
behavior, and improves nicotine withdrawal symptoms. The proposed study consists of a randomized, double-
blind, counter-balanced, crossover human laboratory study of Δ9-Tetrahydrocannabivarin (Δ9-THCV) for daily
smokers. A total of 32 daily smokers will complete two outpatient study visits after 5 days underΔ9-THCV and
matched placebo, during which they will undergo a Smoking Lapse task to assess: (a) the ability to resist
smoking, (b) cigarette smoking self-administration, (c) subjective craving, (d) withdrawal, and (e) subjective
effects of nicotine. This study will test the initial efficacy of Δ9-THCV, which is essential for understanding the
clinical potential of this naturally occurring cannabinoid as a treatment for smoking cessation. Given the wide
prevalence cigarette use and the high acceptability of naturally-occurring products, such as cannabinoids, as
therapeutic agents, the proposed study has the potential to be transformative in uncovering the therapeutic
benefits of Δ9-THCV.

Public health relevance
PROJECT NARRATIVE The proposed study consists of a randomized, double-blind, counter-balanced, crossover behavioral pharmacology study of Δ9-Tetrahydrocannabivarin (Δ9-THCV) for individuals who smoke 10+ cigarettes per day. This study will test the initial efficacy of Δ9-THCV, which is essential for understanding the clinical potential of this naturally occurring cannabinoid as a treatment for tobacco use disorder.